PHASE I TRIAL TESTING GENETICALLY-ENGINEERED INTERLEUKIN-7 MELANOMA

Tumors genetically engineered to produce cytokines will release them locally in a sustained manner, stinulate a host immune cell infiltrate, enhance the recognition of tumor-associated antigens, and generate systemic specific immunity. This hypothesis, which has been supported for various cytokines in several animl tumor models requires direct testing in patients.